Dynamic Nuclear Polarization of Aerosols - A Novel Approach for Imaging Water Vapor and Enabling Lung Imaging

Project Summary
Detecting and characterizing lung disorders and their impacts on the airways by imaging is extremely
challenging due to the low tissue density. Few options exist to characterize the changes in the microscopic
properties of air access and tissue changes in diseases such as asthma, pneumonia, bronchitis, Covid-19, and
chronic obstructive pulmonary disease. MRI with hyperpolarized gasses, such as 3He and 129Xe have been
used to fill this gap, which however have their own limitations related to cost, complexity of implementation,
compatibility of existing equipment, and some non-negligible biological effects of the gasses. This project will
deliver an alternative approach, based on aerosolized hyperpolarized water vapor (AHWV), which will be fully
biocompatible, portable, compatible with existing imaging hardware, and will allow probing lung volume at
different length scales. The approach is based on Overhauser Dynamic Nuclear Polarization (ODNP) of water,
followed by aerosolization of hyperpolarized water such that it can be imaged. For this exploratory program, we
will develop an open-source, low field (0.2T) ODNP system to hyperpolarize water in the liquid phase that will
be rapidly vaporized by an aerosolization reactor. Relaxation properties of water in vapor form will be studied
at different magnetic field strengths, temperatures and aerosolization approaches to determine the optimal
conditions for vapor polarization, delivery into the measurement volume and optimization of sensitivity. The
method will be on a mouse animal model on a 3T animal scanner. Overall, we will establish an effective
method to hyperpolarize and aerosolize water and will develop the necessary tools required to acquire
hyperpolarized water-in-air images in void-spaces. The study is expected to lay the foundation for this new
portable, cost-effective, and flexible imaging modality for the airways.

Public health relevance
Project Narrative Magnetic resonance imaging of the lungs and airways is extremely challenging due to the low tissue density, thus leaving diagnostic abilities for pulmonary disorders and symptoms, such as asthma, pneumonia, bronchitis, Covid-19, and chronic obstructive pulmonary disease inadequately addressed. In this study we will develop an apparatus and method for using specially prepared water vapor for a magnetic resonance imaging modality, which will be portable, fully biocompatible, low cost, and will help to address the current unmet needs in lung imaging and disease diagnostics.